Rational Design of Artificial Hydrogenases

PROJECT SUMMARY/ABSTRACT
Hydrogenases are complex metalloenzymes that generate energy for certain organisms or balance cellular
redox potentials by catalyzing the reversible interconversion between H2 oxidation and H+ reduction,
respectively. Unraveling the intricate details of the function of these enzymes will significantly advance H2-
based, carbon-neutral alternative energy production. However, the complexity of these enzymes due to the
presence of multiple metallic cofactors, low production yield, and deactivation makes studying these enzymes
challenging. Our goal is to design new biomolecular artificial hydrogenases (ArHs) as functional analogs of
these complex metalloenzymes.
De novo design and repurposing of native proteins are appealing and well-established approaches to
creating active sites of complex metalloproteins within minimal protein scaffolds. Although the designed
systems are less complex, they serve as water-soluble functional analogs of the native metalloenzymes and
provide a functional view of the chemistry. Employing these approaches, we propose to pursue two Specific
Aims describing the overall design principles and functional/mechanistic attributes of the ArHs inspired by the
[NiFe] hydrogenases. The overall objectives of this proposal are: i) to design mononuclear, multinuclear, and
heterometallic active sites within designed biomolecular scaffolds; ii) characterize the physical and catalytic
properties of these ArHs; iii) determine the timescales of electron transfer; iv) tune the pKa of ligand and outline
the role of ligand protonation states in H2 evolution; v) identify the metallated species responsible for
noncooperative H2 production; and vi) elucidate how multimetallic sites influence the properties/reactivity,
ultimately attaining a wholesome view of H-H bond formation. Our strong preliminary results presented here
attest that our objectives are achievable.
Collectively, the results from this proposed work will impact the fields of metalloprotein design, bioinorganic
chemistry, and alternative energy research. A novel class of ArHs will emerge, which will provide functional
vignettes into the working principles of H+ reduction related to the native enzymes. The lessons from this study
will enable us to prepare biosynthetic catalysts with novel properties and functions in the future.

Public health relevance
PROJECT NARRATIVE Hydrogenases are complex metalloenzymes that produce H2 gas naturally and, thus, present a significant promise in an H2-based green energy economy if we can decipher how these enzymes function by developing simpler biomolecular systems. Using de novo design and metalloprotein redesign approaches, we will construct artificial hydrogenases with homometallic and heterometallic active sites, determine their physical and catalytic properties and electron/proton transfer pathways, and elucidate how multimetallic sites contribute to the function. Our studies will provide critical mechanistic insights for the development of novel biocatalysts and advancing alternative energy research.